Core B - Instrumentation

CORE B – PROJECT SUMMARY/ABSTRACT
Core B. Instrumentation Core
Nathan Sherer, Core Leader
The Instrumentation and Imaging Core (Core B) provides support for equipment and facilities used communally
by members of the PPG. Aim 1 is to provide priority access to and training in the use of critical instrumentation
used by all Projects including 1) high-speed ultracentrifuges for virus preparation and biochemical studies; 2) an
Azure 600 Imager for nucleic acid and protein detection / quantification; 3) an ABI Prism 7900HT real-time PCR
machine for measuring gene expression; and 4) a Beckman Spectrophotometer DU7400 used for quantitative
assays important to the PPG. Aim 2 is to provide priority access to and instruction in the use of advanced light
microscopy resources including a Zeiss Axioimager suite, a Zeiss Axiovert 200M 3-D deconvolution live cell
imaging microscope, two Nikon Ti-Eclipse live cell imaging deconvolution microscopes, and a fully automated
Nikon A1R confocal microscope; and to facilitate technology development. Aim 3 is to provide PPG members
with crucial shared histopathology services for generating, processing, and visualizing formalin-fixed, paraffin-
embedded and frozen tissue samples for tumor virus-associated cancer studies. Combined, this core has been
extensively used over the current funding period and is now expanded in its capacity to include additional
innovative microscopy and histopathology capabilities, including DNA/RNA fluorescence in situ hybridization
(FISH) services for multiplex tracking of viral and host cancer-relevant gene products in single cells and tissues
and high-resolution 12x expansion microscopy.

Public health relevance
CORE B – PROJECT NARRATIVE The Instrumentation and Imaging Core (Core B) provides shared instrumentation and high-resolution imaging services needed for the success of all Projects in this program. The core also coordinates maintenance and training, and aims to advance the development of new, innovative tools for understanding the replication cycles of cancer-associated viruses and how they cause human diseases.